Integrated Mental Health Fellowship

Project Summary: The proposed T32 Integrated Mental Health Fellowship is designed to train clinician scientists who are
interested in improving the quality of mental health care delivered in primary care, medical subspecialty, and school‐based
clinics. Faculty supervisors will include senior investigators in the University of Washington (UW) Departments of
Psychiatry, Pediatrics, Family Medicine, as well as Kaiser Permanente Washington Health Research Institute, and the Puget
Sound VA Health Services Research and Development (HSR&D) Center for Innovation. The training program combines
mentored research with didactic opportunities in the nationally renowned UW School of Public Health, the NIH Clinical
and Translational Science Award funded UW Institute for Translational Health Sciences and the Fred Hutchinson Cancer
Center. Research training will include graduate level coursework in biostatistics, epidemiology, health services research,
and implementation science, seminars led by program faculty from two NIMH‐funded P50 Centers, statistical consultation,
journal clubs, grant writing bootcamps, and a weekly works‐in‐progress seminar and one‐on‐one mentoring. A strength
of the proposed training program is the longstanding cross‐disciplinary training between psychiatrists, clinical
psychologists, family practice physicians, pediatricians, and health services researchers. Our Integrated Mental Health
Fellowship is the only NIMH‐funded T32 program geographically located in the Pacific Northwest. Over the past 35 years,
this continually funded T32 program has trained 43 fellows, including 38 physicians, and 5 psychologists. According to
Scopus our former fellows have published 1,568 peer‐reviewed journal articles and have been cited 131,464 times. Under
the overall leadership of MPIs Drs. Unützer and Fortney, Co‐Directors Drs. Comtois, Richardson and Bennett will
collaborate in the management of the program including governance, general mentorship, recruitment, selection,
progress monitoring, and career planning for fellows. Two postdoctoral fellows will be admitted to the program each year
such that four fellows will participate at any given time. Recruiting fellows from Underrepresented Racial and Ethnic
Minority groups is prioritized, though we also take an inclusive perspective that diversity also relates to sexual identity,
gender identity, ability, veteran status and disadvantaged background. At the start of fellowship, each fellow’s educational
needs will be formally assessed using a standardized template. This formal assessment of strengths and development
areas will be used to generate an Individual Development Plan. The fellow is expected to re‐visit and update the plan
quarterly, allowing a time for self‐reflection and assessment of their productivity and progress towards their scientific
career goals. Fellows without advanced research degrees will be encouraged to complete a Master of Science degree in
the UW School of Public Health. All fellows will also engage in one or more research projects supervised by their mentors.
The fellows mentors and research projects are proposed as part of the fellowship application process, so progress on
research projects can being immediately upon program entry. By the end of the two‐year fellowship training program,
we expect graduates to be capable of independent work and to be highly competitive for academic research faculty
positions.

Public health relevance
Project Narrative The proposed T32 Integrated Mental Health Fellowship is designed to train clinician scientists who are interested in improving the quality of mental health care delivered in primary care, medical subspecialty, and school-based clinics. Faculty supervisors will include senior investigators in the University of Washington Departments of Psychiatry, Pediatrics, Family Medicine, as well as Kaiser Permanente Washington Health Research Institute, and the Puget Sound VA Health Services Research and Development (HSR&D) Center for Innovation. Postdoctoral fellows will engage in mentored research and receive training in biostatistics, epidemiology, health services research, and implementation science through coursework, seminars led by program faculty from two NIMH-funded P50 Centers, one-on-one mentoring, statistical consultation, journal clubs, grant writing bootcamps, and a weekly works-in-progress seminar.